Structural and functional connectivity of the social decision-making network

PROJECT SUMMARY/ABSTRACT
Humans and numerous other species live in complex social environments, requiring many of our most important
decisions to be made in the context of social interactions. All of our social relationships rely on our ability to make
context-appropriate decisions, including significant ties with committed partners, family, and friends. The social
decision-making (SDM) network hypothesis suggests that the expression of a given social behavior is reflected
by the overall activity of a network of structures rather than activity of any single structure. Although the SDM
network has been proposed on functional grounds, most of the supportive evidence is based on structural
connectivity among loci and on examining the function of individual neurochemicals, brain areas, and neuronal
mechanisms therein. We know surprisingly little about network function that regulates context-appropriate social
behaviors. The socially monogamous prairie vole (Microtus ochrogaster) provides an opportunity to examine the
neural mechanisms underlying social decisions which foster intimate relationships through the study of brain
circuits regulating behavioral choices in interactions with current and potential partners. Our long-term goals are
to dissect the neurocircuitry of social behavior (including the social behavior network and mesolimbic reward
system), define normal and aberrant network activity during context-appropriate and context-inappropriate
behaviors, respectively, and develop precise interventional tools that change circuit dynamics. Our theoretical
neurocircuit of pair bond behaviors centers in five brain structures within the SDM network demonstrated to have
functional specialization in regulating partner-directed affiliative behaviors, stranger-directed aggressive
rejection, or both. Our specific aims will test the following hypotheses: (AIM 1) structural and functional
connectivity between brain regions will vary depending on type of social stimuli and pair bond status; (AIM 2)
Real-time recording in the SDM network will demonstrate that regional and interregional neural firing is distinct
during (a) affiliative vs aggressive, (b) familiar vs unfamiliar, and (c) preferred vs non-preferred social interactions;
and (AIM 3) altering neurochemical inputs into and activation of select projections out of a central hub will
promote shifts in activity across the neural network and adjust what is considered context-appropriate behaviors.
Upon conclusion, we will understand the role of regional and interregional activity within a network which governs
behavioral choices that either enhance or marginalize intimate social ties. This contribution is significant as it will
be the first study to utilize such time-sensitive measurements of neural activity within the SDM network in freely-
moving voles and will service as a proof-of-concept for how this neural network guides decisions in other social
scenarios which impact our most important social relationships. The proposed research is innovative as it
employs simultaneous fast measurement and manipulation of neural activity of the SDM network to better
address many aspects of network connectivity and integrates new technologies into in vole research, which may
serve as a template for how these technologies can be adapted for other non-traditional animal models.

Public health relevance
PROJECT NARRATIVE Intimate relationships represent significant aspects of our social world but can be challenged with the prospect of lack of commitment or unfaithfulness. It is critical that social partners display ‘commitment’ through context- appropriate behaviors, such as selective affiliation to a current partner and rejection (or aggression in some species) of potential partners. The proposed study will employ simultaneous fast measurement and manipulation of interregional neural activity to build a functional circuit in the social decision-making network that regulates context-appropriate behaviors during social interactions which represent signals of commitment to a close relationship.